Groundwork for a Synchrotron MicroCT Imaging Resource for Biology (SMIRB)

Summary/Abstract of the Proposed Project
Phenotypes provide a classical biological approach to studying morphological changes. Under a microscope,
adults and children alike can distinguish a normal cell arrangement like a single row of columnar-shaped gut cells,
and differentiate this normal presentation from an abnormal clustered group of the same columnar-shaped cells.
This distinction occurs by descriptively comparing the abnormal phenotype against normality. For a computer-
based model to make the same distinction, a wild-type reference must be used for comparison. Studies on cellular
phenotyping widely use histological examination to visualize cell morphological changes; however, it induces
sectioning artifacts, thereby preventing the visualization of 3-dimensional (3D) tissue volumes. To circumvent these
challenges, we plan to take advantage of an unbiased form of tissue imaging, termed X-ray computed
microtomography (microCT). MicroCT will be used to develop a standard reference of normal cellular phenotypes
needed to lay a foundation for automated segmentation and computational phenotyping. Unlike conventional
histology, the imaging technology of microCT, which amounts to a non-destructive form of histology for small metal-
stained biological samples, will enable 3D visualization of cell types in the micrometer range. The novel scale and
resolution of microCT will thereby reveal the 3D morphology and spatial distribution of cells to quantify and
characterize phenotypic variations across vertebrate and invertebrate models. Combining the resolution of
microCT imaging with machine learning, we will apply supervised-manual segmentation to microCT datasets to
create computational cell recognition mechanisms for morphological assessment. This integration will include
open-source tools and devices that will enable community-driven research and data-sharing. As an added benefit
of this AI integration, our computational approach will further assist in augmenting large amounts of data required
to examine the statistical association of cellular phenotypes.
To demonstrate the applicability of our methodology for phenotypic characterization in any given cell type or
organism, our pilot for this project will focus on the single-variable approach of ‘gut epithelial cells’ across three
organisms (i.e., zebrafish, daphnia, froglets). By prioritizing phenotypic investigation of these specialized cells to
the analogous relationship of mammalian intestinal cells, this work will establish a practical foundation to increase
our understanding of the 3D biological structure of wild-type cells, and advance morphological cellular phenotyping
in whole-organisms for quantitative, histological, disease recognition.

Public health relevance
Narrative of the Proposed Project Automated phenotyping of wild-type cells provides a computational approach for detecting structural variations, which is essential for histopathological diagnosis. Given the limitations of serial sectioning, the proposed project aims to use 3D microCT imaging to quantify and characterize phenotypic variations of a specific cell type across three wild-type model systems, with potential applications in other model organisms. The use of this X-ray histotomography technique has the spatial resolution necessary to study detailed cellular features for morphological analysis that can expand to disease and human biopsy samples for human health correlation.